Germline risk of oral and oropharyngeal cancers across diverse populations

PROJECT SUMMARY/ABSTRACT
There is striking geographical variation in head and neck cancer squamous cell carcinoma (HNSCC) incidence
globally. Some of the highest incidence rates have been observed in Southern and Eastern Europe and South
America. The continual high HNC burden in these regions necessitates strong collaborative networks to
assess susceptibility loci across and within ancestral backgrounds. This application brings together leading
international groups with large, well characterized study populations, to investigate the role of germline
variation in oral cavity and pharynx cancer in the largest genome-wide association (GWA) study of HNC to
date. Previous data from 6035 cases and 6585 controls will be combined with recently generated data,
supported by NIDCR and the Center for Inherited Disease Research (CIDR), from 4 IARC multi-center studies
and 7 studies from Canada, US, UK, South America and Iran. Genotyping data from a total of 11,378 cases
and 12,335 controls are included in the proposed work. Additionally, human papillomavirus (HPV) status will be
available for all 4,454 oropharynx cancer cases, allowing a powerful stratified analysis by this important risk
factor. Finally, the diverse populations included here will allow for identification of trans-ethnic and population-
specific germline susceptibility variants to characterize susceptibility to varying risk for HNC across
populations. The proposed project will define the role of the genetic factors involved in risk of HNSCC in
European, North American, South American and Middle Eastern populations which may result in earlier
detection and improved prevention and treatment strategies for HNSCC globally.

Public health relevance
PROJECT NARRATIVE Improved understanding of the germline architecture and risk variants that drive oral cavity and oropharyngeal tumors by etiologic factors would significantly enhance the development of effective and more personalized prevention and early detection. The need for inclusion of diverse populations in this regard is critical for equitable global impact. This proposal will utilize existing data from populations across four global regions to conduct the largest study to date on the role of germline variants in risk of oral cavity and oropharyngeal cancers.